Mechanisms of innate immune dysfunction in SIV/malaria co-infection in pregnancy

PROJECT SUMMARY/ABSTRACT
HIV remains one of the world’s most devastating diseases, with more than 38 million people living with HIV
(PLWH) and an additional 1.7 million new infections per year. Moreover, in 2019, infection with malaria was
reported to have reached 229 million cases worldwide and caused over 409,000 deaths. Although advances
have been made in reducing the incidence of both HIV and malaria, the risk of infection with either disease is
still great, especially in resource-limited countries. Importantly, the geographical overlap in endemic HIV and
malaria constitutes a high risk for co-infection, fueling transmission and pathogenesis of both diseases. The
burdens of HIV and malaria are particularly elevated in pregnant women, leading to increased risk of poor birth
outcomes and maternal and infant mortality. Notably, malaria in pregnancy (MIP) in women living with HIV (WLH)
results in even greater risk of adverse outcomes and the treatments currently available for MIP have only shown
limited success in WLH. Therefore, our long-term goal is to identify key factors in MIP immunopathogenesis to
aid in development of new therapeutics that can safely and effectively reduce maternal and fetal morbidity and
mortality in WLH. The overall objectives for this application are to (1) dissect the pathogenic outcomes of P.
fragile infection in SIV+ pregnant rhesus macaques (RMs) and (2) mechanistically elucidate the role of
neutrophils and innate lymphoid cells (ILCs) in decidual inflammation during SIV/P. fragile co-infection. Our
central hypothesis is that P. fragile and SIV co-infection of pregnant RMs will result in greater placental
parasitemia and dysfunction that associates with higher levels of decidual neutrophil accumulation and ILC
activation, as compared to mono-infected or healthy RMs. The rationale for the proposed research is that a better
understanding of the complex interplay of neutrophils and ILCs in placental dysfunction will promote subsequent,
targeted studies to leverage our findings to develop novel interventions to treat MIP in WLH. The central
hypothesis will be tested by pursuing three specific aims: 1) To identify key pathogenic consequences of P.
fragile infection and the impact of SIV co-infection during pregnancy; 2) To define the role of neutrophils in
peripheral and decidual inflammation during co-infection of pregnant RMs; and 3) To determine the role of ILCs
in regulating peripheral and decidual inflammation in co-infected pregnant RMs. The proposed research is
innovative because it focuses on using a highly translational animal model to open new scientific horizons on
key alterations in innate immune function that drive poor maternal and fetal outcomes in SIV and P. fragile co-
infection, which closely parallels the dynamics of HIV and P. falciparum infection. The proposed research is
significant because it is expected to provide a strong, evidence-based foundation for future pre-clinical studies
of the biological mechanisms of MIP in WLH. Ultimately, these studies will provide new opportunities to develop
therapies and prevention strategies to reduce morbidity and mortality due to malaria in highly vulnerable WLH.

Public health relevance
PROJECT NARRATIVE The proposed studies aim to leverage a physiologically relevant non-human primate model of both HIV and malaria to identify key immune factors that drive poor maternal and fetal outcomes during infection in pregnancy. Establishing such immune mechanisms would create potential for considerable advances in the identification and pre-clinical testing of novel therapeutic strategies to restore health in women living with HIV who become infected with malaria during pregnancy. The proposed research is relevant to the mission of the NICHD as it will significantly contribute to the ultimate goal of reducing the substantial burden of malaria infection in vulnerable women living with HIV.